Investigating ELSI issues that may facilitate or impede clinical translation of epigenomic research

Environmental factors that increase or decrease disease risk may do so by chemically
altering parts of the DNA that regulate gene expression. These modifications to the
genetic code are referred to as “epigenetics.” Epigenetic changes can be acquired via a
variety of exposures, including pollution and lifestyle behaviors. The benefit or harm of
these changes depends on the purpose of the gene and how the change alters gene
expression. Communication strategies that help people understand and use epigenetic
information are needed to facilitate the translation of epigenetics research to clinical
settings. Our objective is to facilitate the translation of basic epigenomics science into
clinical and public health practice by developing epigenetic communication strategies
that are understandable and useful to the public. The specific aims will: 1) Determine
how people come to understand epigenetics information; (2) Examine how public
perceptions of the benefits and risks of epigenetics research might facilitate or impede
(a) understanding of epigenetics concepts and (b) acceptance of using epigenetic
technologies in clinical settings; (3) identify strategies for communicating information
about epigenetics in a way that increases understanding of epigenetic concepts and
increases acceptance of using epigenetics in clinical settings; and (4) Evaluate the
generalizability of the findings from Aims 1-3 to the U.S. population. We will use an
exploratory sequential mixed methods design that includes one qualitative phase
followed by two consecutive quantitative phases. The qualitative phase will include 20
focus groups (N=160 total, n=8 per group). The quantitative phases will include a
nationally survey (N=1,870) and a full-factorial experiment (N=1,954). Our proposed
research will overcome a critical barrier to the translation of basic epigenetics research
into clinical and public health practice: limited scientific knowledge about how to
communicate about epigenetics in way a that is understandable and useful to the public.
Furthermore, our findings could be used as a foundation for research that communicates
information about other emerging genomics technologies to the public. We will expand
our impact further by developing a toolkit for disseminating our discoveries.

Public health relevance
Few people realize that pollution and some behaviors like physical activity and tobacco smoking can affect their health by “turning on” or “turning off” certain genes through a process called “epigenetic modification.” This study will develop and test strategies for communicating about epigenetics that are understandable to members of the public.